Ventral Pallidum Circuits Underlying Preclinical Models of Opioid Addiction

Project Summary
Addiction, and opioid use disorder (OUD) in particular, is a scourge on American life. Though we know much
from animal models about how opioid drugs act on the brain, we have yet to develop new OUD treatments based
on this knowledge. Why is this? Our lab, like others in recent years, have argued that in part it is due to a lack of
translationally-relevant rodent models that capture the key behavioral features of addiction, such as the
maladaptive, compulsive, and relapsing use that develops in a subset of individuals.
In humans, OUD is characterized by continued use of opioids despite negative consequences, preoccupation
with using these drugs, and relapse to drug use after quitting, and for long-lasting opioids like heroin, also
escalation of use, tolerance, and withdrawal. Each of these translationally-relevant behavioral phenomena can
now be modelled in rodents, but the neural networks underlying each of them are yet poorly understood.
The ventral pallidum (VP), and especially its dense projections to the ventral tegmental area (VTA), have
drawn increasing attention for their potent roles in motivation and addiction. We recently showed VP neurons
are essential for translationally-relevant cocaine relapse-like behavior, and that GABAergic VP neurons (VPGABA)
and their projections to VTA are specifically responsible for a range of strongly motivated behaviors—presumably
via interactions with wider neural networks of motivation. We hope that by understanding how these neural
networks function during behaviors that capture key aspects of OUD, we can leverage this information to develop
new neuroscience-based treatment strategies.
Here, we systematically dissect the involvement of VPGABA neurons, and the wider reward and aversion
networks they modulate, in OUD-relevant behaviors. In well-validated GAD1:Cre transgenic rats, we use Cre
and Flp-dependent chemogenetic manipulations to show how VPGABA neurons 1) modulate wider networks
underlying opioid relapse, 2) participate via their functionally-segregated outputs in appetitive aspects of OUD,
and 3) how these pathways mediate aversive aspects of OUD. We hypothesize that VPGABA neurons modulate
wider neural networks to generate OUD behaviors, and that inhibiting this key pathway will reduce compulsive
drug seeking.

Public health relevance
Project Narrative This decade has seen an explosive, devastating epidemic of opioid use disorder (OUD) in the U.S. Yet few treatments for OUD have emerged from neuroscience, perhaps in part due to a failure of conventional rodent models to capture fundamental behavioral aspects of the disorder. Using state of the art tools for manipulating and determining activity within brain circuits and networks during translationally-relevant behaviors in rats, we determine the specific roles of GABAergic ventral pallidum neurons in OUD-like behaviors, thus potentially opening new therapeutic avenues to treat addiction.